Overcoming Immunological Barriers to Inhaled AAV Gene Therapy

PROJECT SUMMARY/ABSTRACT
Gene therapy has made significant progress in recent years, with FDA approvals for liver and muscle
disorders. However, lung-directed gene therapy lags behind due to unique challenges posed by vector tropism
and mucosal immune responses. While inhaled gene is being explored in lung disorders such as Cystic
Fibrosis (CF), primary ciliary dyskinesia, pulmonary arterial hypertension, and lymphangioleiomyomatosis,
clinical trials with AAV-mediated gene delivery have identified two major barriers to successful, long-term gene
expression: (1) cross presentation of AAV capsid and elimination of transduced cells by CD8+ cytotoxic T-
lymphocytes (CTLs), and (2) potent humoral responses which prevent administration in seropositive individuals
by immune responses. These immune responses limit treatment effectiveness in the liver and muscle, but their
role in the context of lung-directed gene delivery has not been explored.
Our lab has carried out foundational studies investigating the unique mucosal niche where B- (BRM) and T-
(TRM) resident memory cells arise in response to local antigen, ready to respond rapidly upon re-exposure.
Specifically, we have discovered that B cells, rather than dendritic cell are key antigen-presenting cells (APCs)
for fungal antigens in the lung. However, their role in the context of inhaled gene therapy is not known. Based
in part that αCD20 has been used in CF lung transplantation and is well tolerated, we investigated αCD20 in
the context of lung gene therapy. Our preliminary data indicate αCD20 antibody prior to primary adenoviral
vector administration blocks the generation of BRM cells, attenuates activated CD8+ TRM and completely
rescues secondary gene transfer. In my preliminary studies, I have identified a critical role for airway
immunoglobulins (Igs) in limiting re-dosing with unimpeded secondary adenoviral airway gene transfer
occurring despite the formation of serum anti-vector antibodies (in review). In this proposal, we will investigate
this strategy for clinically relevant AAV vectors. Based on this, we hypothesize that that lung epithelial tropic
AAV6.2 elicits lung CD8+ and B-cell resident memory cells and that administration of αCD20 prior to vector-
based gene transfer in the absence of preexisting immunity will attenuate these responses and allow more
efficient repeated vector delivery. In Aim 1, we will test the hypothesis that AAV6.2 delivery to the respiratory
tract will elicit mucosal resident-memory immune responses that limit redosing. In Aim 2, we will test the
hypothesis that αCD20 treatment prior to primary vector delivery to the lung can prevent B- and T-cell
responses and permit re-dosing.

Public health relevance
PROJECT NARRATIVE Inhaled gene therapy holds promise for the treatment of genetic lung diseases. However, immune responses in the lung are likely to present a barrier to effective treatment and prevent drug re-administration. The goal of this proposal is to understand these responses and attempt to ameliorate them by repurposing FDA-approved immunomodulatory agents.